Development of Diverse Assay Formats to Study the Interaction of Glucokinase (GCK) with Glucokinase Regulatory Protein (GKRP) and Analysis of the Effect of Clinical Mutations on GKRP

Project highlights: executed the HTRF screen and an HTRF counterscreen. Developed two confirmatory assay formats. During this period, the NCGC has fostered and maintained over 180 active collaborations with both NIH and extramural investigators, facilitating drug discovery efforts across the entire spectrum of human disease. These efforts have led to over 100 high-throughput screens and nearly 60 medicinal chemistry campaigns, providing our collaborators and the general research community a wealth of publications and promising small molecule leads. In addition, the NCGC has undertaken a number of informatic challenges to make better use of existing drug and disease target information and provide the general public with easily accessible resources, further catalyzing the development of new therapies for human disease.